Genomic profiling of single circulating tumor cells in the precision medicine of metastatic prostate cancer

PROJECT SUMMARY AND ABSTRACT
Metastatic castration-resistant prostate cancer (mCRPC) is the most lethal state of prostate cancer (PCa) and
remains as the most challenging issue in PCa treatment. The development of more effective treatments for
mCRPC is a significant unmet clinical need. There are substantial heterogeneities in treatment responses of
mCRPC, necessitating the use of more personalized strategies in guiding treatment based on the specific
genomic characteristics of individual patients. There are considerable limitations in using the traditional tissue-
based genomic profiling to guide mCRPC treatment, partly because mCRPC is a bone-predominant metastatic
disease, thus tissue samples are difficult to obtain and yields are generally low. Moreover, during treatments,
the genomic profiles of tumors may change quickly to evade therapeutic or immune attacks, leading to drug
resistance. In order to promptly and accurately capture these changes and adjust treatment plans, repeated
tumor biopsies would be needed, which is difficult to perform in routine clinical practices given the invasive and
bone-predominant nature of mCRPC. Therefore, in order to improve mCRPC prognosis, it is highly important
to develop novel, non-invasive liquid biopsy approaches to real-time monitor treatment response and guide the
use of different treatments. Circulating tumor cells (CTCs) are shed from tumors into blood and have extremely
high malignant potential, and are arguably the most important subset of tumor cells to monitor and treat. CTCs
can be non-invasively and repeatedly enumerated in real-time, and have exhibited promising prognostic
potentials, as evidenced by the FDA-approval of the CellSearch platform for CTC enumerations as an
independent prognostic factor of several metastatic cancers including mCRPC. However, national guidelines
have not unanimously endorsed the use of CTC enumeration in routine clinical practices, mostly because it
remains unclear what actions should be taken for high-risk patients with elevated CTCs. These facts highlight
the importance of moving beyond CTC enumeration and towards in-depth genomic characterizations of CTCs.
Large studies on single-cell CTC analysis have been rarely reported, partly due to the significant challenges on
single-CTC detection, isolation, whole genome amplification (WGA), and sequencing bias identification and
correction. We have established a comprehensive pipeline on the enrichment, enumeration, isolation, WGA,
sequencing, and data analysis of single CTCs. Based on three PCa patient cohorts at the Sidney Kimmel
Cancer Center, MD Anderson Cancer Center, and George Washington University Cancer Center, we will
conduct genomic profiling of single CTCs to identify markers of treatment response and prognosis. To our best
knowledge, this is the first large population-based study of single-CTC analysis in mCRPC. Findings from this
study will significantly improve the potential of the clinical application of CTCs in mCRPC management, by
precisely tailoring treatment to the genomic make-up of individual CTCs from individual patients.

Public health relevance
PROJECT NARRATIVE We will use a population-based approach to conduct whole exome sequencing and targeted gene panel sequencing of single and pooled circulating tumor cells (CTCs), in order to identify CTC mutations/genes that are predictive of treatment response and prognosis in patients with metastatic castration-resistant prostate cancer (mCRPC). As, to our best knowledge, the first population study of single-CTC next-generation sequencing study in mCRPC, the findings of our study will significantly improve the potential of CTCs in the clinical management of mCRPC, by precisely tailoring treatment to the genomic make-up of individual CTCs from individual patients.